NIDDK DATA REPOSITORY SERVICES

This NIDDK Data Repository contract will strengthen, enhance, and expand the capabilities of the NIDDK Central Repository into new areas aligned with advances in data sharing and data science that may include indexing phenotypic data; storing, querying, and sharing data with higher complexity or digital images through transfer or visualization; working with electronic health records, data standardization terminologies, or the OHDSI program and the OMOP CDM to support clinical research; experience with data analytics, machine learning, or artificial intelligence; and exploring making resources available through a cloud environment. Enhancements and expansion in these areas will improve access to and potential uses of resources held by the NIDDK Central Repository, thereby maximizing their scientific value and utilization by the research community, and allow the NIDDK to explore or adapt to innovations that align with future aims and priorities of the NIDDK and NIH.